CORE--Morphometric

Principal Investigator/Program Director (Last, First, Middle): Stenmark, Kurt Core B CORE FUNCTION The morphometry Core (Core B) will provide support for research projects 4 (Stenmark) and 5 (White) to assess the effects of [unreadable]on vascular development and alveolarization in the neonatal lungs. The